Development and Initial Efficacy Testing of a Cognitive-Behavioral Intervention to Treat Adolescent Binge Eating

PROJECT SUMMARY/ ABSTRACT
Binge-eating episodes involve eating an unusually large amount of food and feeling unable to control the type
or amount of food consumed while eating. Among adolescents, loss-of-control (LOC) eating is a precursor to
excess weight gain and binge-eating disorder. Binge/LOC eating is also associated with physical and mental
health impairments, and psychosocial distress. Although excess weight and binge/LOC eating have serious
immediate and long-term consequences, assessment and treatment have received minimal attention for
adolescent patients. Among adults, cognitive-behavioral therapy (CBT) has a strong evidence base for binge-
eating disorder. Among adolescents, there are no well-established treatments for binge/LOC eating.
Adolescents have unique social, cognitive and emotional needs because of their developmental stage; unique
treatment approaches are essential to meet these unique needs. This Mentored Patient-Oriented Research
Career Development Award (K23 with Clinical Trial) builds upon the candidate’s programmatic clinical-
research interest in the treatment of weight and eating disorders. Training objectives and research activities for
this K23 are to develop new skills and expertise in (a) treatment development and initial efficacy testing as
described by the Stage Model of Behavioral Therapies Research, and (b) advanced statistical skills for
repeated and dyadic data. Development of CBT for adolescent binge/LOC eating will make a significant
contribution to our understanding of treatment in an important step towards reducing health impairments and
psychosocial distress associated with adolescent binge/LOC eating and excess weight. Research activities are
tightly integrated with training activities and mentorship from an advisory team of internationally-recognized
scholars to facilitate the candidate’s development of necessary skills to become an independent and impactful
investigator in the fields of childhood obesity and eating disorders.
The training plan enlists the mentorship of Carlos Grilo, PhD, Professor of Psychiatry and Psychology and
Director of the Yale Program for Obesity, Weight, and Eating Research, and Wendy Silverman, PhD, Alfred A.
Messer Professor in the Yale Child Study Center and Professor of Psychology and Director of the Yale Child
Study Center Program for Anxiety Disorders. Dr. Grilo’s expertise in the treatment of adult binge-eating
disorder and obesity is complemented by Dr. Silverman’s expertise in youth treatments. Together, their
mentorship will facilitate successful execution of the proposed research aims and career objectives. Research
and training activities will also make use of other clinical-research educational programs at Yale (e.g., CTSA,
Psychotherapy Development Center) that offer many formal training activities, opportunities, and resources.
Skills (treatment development and advanced statistical analysis) will yield a new treatment and initial efficacy
data for future tests of efficacy and effectiveness throughout the candidate’s career.

Public health relevance
PROJECT NARRATIVE Youth who engage in binge/loss-of-control eating (patterns of discrete eating episodes that involve feeling unable to control the type or amount of food consumed while eating) are at high risk for excess weight gain and physical and mental health impairment. As there are few evidence-based treatments for adolescents with binge/loss-of-control eating, a clear clinical priority is adolescent treatment development research, such as the modification of cognitive-behavioral treatment (CBT) for binge-eating disorder, which has a strong evidence base for adult patients. The proposed training plan—treatment development and initial efficacy testing guided by the Stage Model of Behavioral Therapies Research, and advanced statistical training—can help improve understanding of the treatment of adolescent binge/loss-of-control eating.